Addressing the burden of untreated HIV in cancer patients in sub-Saharan Africa: feasibility and planning for a pragmatic clinical trial

ABSTRACT
In sub-Saharan Africa (SSA), the dual burdens of HIV and cancer pose challenges to health systems and
exacerbate global inequities. People living with HIV (PLWH) are at higher risk of developing certain cancers, are
less likely to receive cancer treatment, and experience higher cancer-specific mortality than persons without HIV.
Antiretroviral therapy (ART) mitigates negative impact of HIV in certain cancers and may be critical to the success
of cancer treatment among patients with cancer and HIV by decreasing immune exhaustion and restoring
immune function. Despite this, there remains a lack of evidence-based recommendations for the integration of
HIV treatment and cancer care, and for coordinating treatment initiation for ART-naïve people with cancer.
Current guidelines for treating HIV in people with cancer are based on expert opinion, are not tailored for low-
resource settings, and do not address the exact timing of ART initiation for patients who present with untreated
HIV and different types and stages of cancer, and at different levels of immunosuppression. We call on the
tremendous successes of a paradigm shift in integrated TB/HIV care that occurred following 3 large effectiveness
trials of how and when to initiate ART in PLWH presenting for TB treatment. In Aim 1 of this proposal, we will
measure the burden of treated and untreated HIV, and undiagnosed HIV among cancer patients, with focus on
recent HIV diagnoses and proportion of patients who could benefit from initiation of ART during cancer treatment
at regional cancer centers in Malawi, Zimbabwe, and South Africa. In Aim 2, we will evaluate systems-based
barriers and facilitators to integration of cancer and HIV treatment using a theoretical domains framework and to
identify ways to provide integrated care with cancer center staff and key stakeholders. In Aim 3, we will develop
design strategy for a multi-country pragmatic clinical trial. We will perform process mapping to identify
intervention points to coordinate HIV and cancer care and conduct discrete choice experiments with
multidisciplinary staff to solicit feedback on design of a future randomized hybrid effectiveness-implementation
trial of ART initiation strategies at regional cancer centers in Malawi, Zimbabwe, South Africa, and Uganda.
We contend that ART as integral for HIV-associated cancer treatment is well generally supported, broadly
available, and yet not uniformly a part of current cancer therapy in SSA. We are proposing the first multinational
collaboration planned to address the HIV treatment component of HIV-associated cancer: this topic has not been
fully addressed due to complex, siloed treatment systems and focus on the cancer component of care for people
with cancer and HIV. Using the results of this planning work, we will propose the appropriate hybrid trial design
to determine evidence-based ART initiation timing in a selected set of cancers, and to evaluate the impact of
coordinated ART provision on both clinical outcomes including overall survival and adverse events, as well as
implementation outcomes, such as initiation and persistence on ART, completion of intended cancer therapy,
and HIV care transitions following completion of cancer therapy.

Public health relevance
PROJECT NARRATIVE The overarching goal of this project is to prepare for a hybrid clinical effectiveness- implementation trial to evaluate best practices for initiating antiretroviral therapy for persons with previously untreated HIV and cancer in sub-Saharan Africa. We will first determine the burden of treated and untreated HIV among cancer patients, and then use a multi-modal approach to evaluate systems-based barriers to concurrent treatment of HIV and cancer at regional cancer referral centers in Zimbabwe, Malawi, and South Africa, and Uganda. The future trial will evaluate strategies to use antiretroviral therapy to improve cancer survival and treatment side- effects, as well as improve delivery of coordinated cancer and HIV care.